Neurobiological mechanisms of daily life activity participation in older adults

Project Summary
The proposed research will use behavioral, psychophysiological, neuroimaging, and naturalistic approaches to
understand the mechanisms underlying daily life activity participation in older adults and its linkages to
Alzheimer’s disease pathology. There is a strong foundation of research demonstrating reliable age-related
decreases in many aspects of cognitive ability that are coupled with changes in the neuromodulatory systems
that support these functions. Yet older adults also seem to experience clear shifts in motivational prioritization,
encountering increased costs associated with engagement in cognitively effortful activities. Likewise, older
adults report an overall decrease in participation in cognitively effortful activities in daily life. However,
engagement in cognitively effortful activities has been associated with the maintenance of cognitive function
and decreased risk of developing Alzheimer’s disease in older adulthood, underscoring the critical need to
understand the relationship between motivation and changes to neuromodulatory systems in older adulthood,
and how these might impact older adults’ daily life engagement in cognitively effortful activities, to be able to
promote cognitive health in older adults. The current proposal provides a novel perspective on this issue, by
employing a multilevel, multimodal framework to study the behavioral and neurobiological mechanisms
underlying age-related shifts in the motivation to perform cognitively effortful activities, and to directly link these
changes with daily life activity participation and Alzheimer’s disease pathology. The project directly tests the
hypothesis of age-related motivational reprioritization and its relationship to activity participation by using the
combination of ecological momentary assessment (EMA) and passive sensing approaches involving repeated
sampling of older adult daily life activity participation. Further, these rich naturalistic observations of daily life
activities are coupled with PET imaging measures of catecholamine synthesis (i.e., dopamine, norepinephrine)
and behavioral and psychophysiological measures of cognitive effort in older adults to test for the relationships
between cognitive effort-related motivation, neuromodulation, and daily life activities in older adults. Finally, the
project will feature the first-ever assessment of the relationship between in vivo markers of Alzheimer’s disease
pathology and daily life activity participation in older adults, using state-of-the-art tau PET and intensively
sampled daily life activity participation assessed with both EMA and cutting-edge passive sensing methods. A
key component of the project is its exploration of mobile technologies as a means to monitor older adult activity
participation during daily life, and their potential utility as a tool to enhance cognitive engagement. As such, the
proposed work represents an essential first step in developing both behavioral and biological targets for
motivational interventions that promote the maintenance of cognitive health and resilience to pathology in older
adulthood.

Public health relevance
Project Narrative Engagement in cognitively effortful activities is thought to be important for the maintenance of cognitive function and resilience to age-related pathology, however, despite the potential importance of engaging in cognitively effortful activities, older adults actually report decreased participation in these types of activities in daily life. This project will provide critical and detailed information regarding the behavioral and neurobiological mechanisms of daily life activity participation in older adults and its relationship to Alzheimer’s disease pathology. Such information has clear relevance for public health, by improving understanding of how and why aging might lead to a motivational shift that contributes to changes in activity participation, and in developing appropriate interventions to address such changes.